Implementing Voluntary National Retail Food Regulatory Program Standards (VNRFRPS

PROJECT SUMMARY The mission of the City of Milwaukee Health Department (MHD) is to ensure that services are available to enhance the health of individuals and families, promote healthy neighborhoods, and safeguard the health of the Milwaukee community. Foodborne illness is a significant public health issue, with one out of every six people nationwide experiencing a foodborne illness each year resulting in tens of millions of acute illnesses, hundreds of thousands of hospitalizations, and thousands of deaths each year in the United States. The MHD recognizes that a robust regulatory program is necessary to assure the safety of the food in Milwaukee. In order to assure the adequacy of MHD's regulatory program, MHD seeks to adopt the Voluntary National Retail Food Regulatory Standards (VNRFRPS). The specific aim of the proposed project is to develop a robust regulatory program that meets all of the conditions laid out in the VNRFRPS, by August 31, of 2017. The Milwaukee Health Department will utilize its practical regulatory experience to apply quality improvement (QI) methodology and public health theory (health education, communication, and community organizing) to regulatory food activities in order to meet the VNRFRPS. Evaluation will be integrated throughout the project through the utilization of rapid PDSA cycles to review and evaluate programmatic changes. A five member Standardization Implementation Team will be assembled to lead the overall project.

Public health relevance
PROJECT NARRATIVE Foodborne illness is a significant public health issue, with one out of every six people nationwide experiencing a foodborne illness each year resulting in tens of millions of acute illnesses, hundreds of thousands of hospitalizations, and thousands of deaths each year in the United States. The Milwaukee Health Department recognizes that a robust regulatory program is necessary to assure the safety of the food in Milwaukee. The Voluntary National Regulatory Program Standards provide a defined set of critical elements necessary to assure an adequate regulatory program is in place, therefore, this proposal outlines how MHD intends to try to meet each of the aforementioned standards. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The City of Milwaukee Health Department (MHD) recognizes that a robust regulatory program is necessary to assure the safety of the food in Milwaukee. In order to assure the adequacy of MHD's regulatory program, MHD seeks to adopt the Voluntary National Retail Food Regulatory Standards (VNRFRPS). The specific aim of the proposed project is to develop a robust regulatory program that meets all of the conditions laid out in the VNRFRPS, by August 31, of 2017. The Milwaukee Health Department will utilize its practical regulatory experience to apply quality improvement (QI) methodology and public health theory (health education, communication, and community organizing) to regulatory food activities in order to meet the VNRFRPS. Evaluation will be integrated throughout the project through the utilization of rapid PDSA cycles to review and evaluate programmatic changes. A five member Standardization Implementation Team will be assembled to lead the overall project. The following is a list of deliverables that will result from the successful completion of this project: " An annual VNRFRPS Self-Assessments and Verification Audit (when applicable) " Updated Milwaukee City Ordinances related to food " A New Employee Orientation, Continuing Education, and Field Evaluation Policy " A Pre-Inspection Curriculum and Field Observation Template Training Plan " A Trainee Field Experience Checklist " An Independent Inspection Review Form " An Individual Continuing Education Planning Template " A Training Needs Assessment " A Master Training Schedule and a Listing of Approved Courses and Associated Competencies " A Training Request and Competency Evaluation Form " A Field Standardization Policies and Procedures " A Training, Observation and Standardization Tracking Database " Annual Field Standardization of Inspection Staff " An updated Code Variance Policy " An updated HACCP Policy " A Risk Based Inspection Policy " A HACCP Compliant Electronic Inspection System " A Quality Assurance Policies and Procedures " A Quality Assurance Checklist " An Operator Satisfaction Survey " Annual Quality Assurance Staff Evaluations " Annual Food Safety Audit/Risk Factor Study " A Foodborne and Waterborne Illness Outbreak Response Protocol " A FBI Training and Exercising Policy " A FBI Data Review and Analysis Policy " A Compliance and Enforcement Policy " A Compliance and Enforcement Audit Program " A Community Needs and Capacity Assessment " A Milwaukee Food Safety Advisory Committee (MFSAC) will be convened " An updated MHD website updated " A Food Safety Educational Ttoolkit " Online Inspection Reports " Audience tested educational materials " Updated budget projections " An equipment Tracking System " A Revised Inspection/Licensing Fee System